SDBA-Solutions to Diabetes in Black Americans

PROJECT SUMMARY/ABSTRACT – Solutions to Diabetes in Black Americans National Resource Core
The goal of the Solutions to Diabetes in Black Americans National Resource Core (SDBA) is to provide content,
conceptual, and methodological expertise to improve the effectiveness and sustainability of translational type 2
diabetes (T2DM) and obesity research with Black populations. The SDBA will serve as a National Resource Core
to Washington University Center for Diabetes Translation Research (WU-CDTR) investigators located across the
country. The importance of a specific focus on T2DM in Black Americans is compelling, both in terms of the
disproportionate health burdens and the need for more effective interventions that reach Black communities at
large. Studies have demonstrated the potential efficacy of weight loss for T2DM prevention and control in diverse
populations, including in Black Americans. However, these research findings have not been effectively translated
or scaled to reach Black populations at the level needed to significantly reduce T2DM disparities. Moreover,
epidemiologic evidence and experience in practice point to aspects of social, economic, and policy contexts that
pose specific challenges for intervention effectiveness with Black populations.
The SDBA Core is affiliated with the Council on Black Health, a national research and action network
located at Drexel University in Pennsylvania. The Council mission is “to develop and promote solutions that
achieve healthy Black communities,” with academic and community partnerships as a major strategy. The
Council’s member network includes established and emerging scholars and community-based research partners,
primarily Black Americans, located in 22 U.S. communities. The SDBA Core provides a focal point within the
Council for the dedicated focus on T2DM and obesity research.
As a National Resource Core, the SDBA provides novel and critical services that support a wider scientific
community of WU-CDTR members on a national level. The specific aims for the SDBA Core are to: (1) provide
foundational knowledge about effects of historical oppression and structural racism on current contexts for viable
and sustainable interventions on T2DM, obesity, and related risk factors for Black Americans; (2) advance the
use of systematic approaches incorporating social determinants of health, cultural, and other contextual
influences in diabetes translation research with Black populations; and (3) increase the capacity of WU-CDTR
investigators to address critical gaps in diabetes translation research with Black populations.
The SDBA will allow for further growth of the WU-CDTR network of scholars conducting research on the
root causes of T2DM in the Black population.